EVALUATION AND VALIDATION OF EXHALED NITRIC OXIDE (N0)

The specific aim of this investigation is to develop the technique of measuring exhaled nitric oxide (NO) in asthmatics so that it may be used as a marker of airway inflammation in future therapeutic trials.